Cancer Classifiers Based on RNA Sensors in Living Cells

Abstract
There is a critical need for RNA sensors in living mammalian cells. With the advent of single-cell RNA
sequencing, the transcriptome of any cell type is readily obtainable if not already available. In contrast, we are
still in urgent need for a universal method to act on such transcriptomic information. If we can genetically express
arbitrary effector proteins in specific cell types according to their transcriptional markers, we would transform
large swaths of basic research and biomedical applications, such as immunology, neuroscience, and cancer
therapy. In addition, we would like such sensors to be programmable and operate at the post-transcription level.
One promising use case that would benefit from such sensors is cancer ablation, using an approach
dubbed “circuits as medicine”, where a genetic vector encoding an entire “circuit” (metaphor for a collection of
biomolecules engineered to regulate each other and implement specific functions) is delivered intracellularly.
The circuit will sense the cellular states based on hallmarks of cancer (i.e., the overexpression of specific RNAs
or the presence of specific mutations), process the signals, and deliver specific therapeutic payloads accordingly
in cancer cells, directly killing them while educating the immune system to search and destroy other cancer cells.
Previous efforts largely relied on strand displacement, a successful strategy for nucleic acid-based signal
processing outside cells. However, their functionality has remained inadequate inside living mammalian cells,
most likely because the double-stranded RNA (dsRNA) formed during strand displacement signals viral infection
and are actively engaged by mammalian proteins in the immune pathways. We hypothesize that, because it is
impossible to evade the omnipresent dsRNA-interacting proteins, it is wiser to embrace them. In this proposal,
we will leverage endogenous human enzymes that recognize and specifically edit dsRNA, to create sensors that
can be programmed to respond to arbitrary RNA transcripts (“triggers”).
First, we will use fast design-build-test cycles in vitro to optimize sensor performance. We will focus on
increasing sensor output in response to triggers by engineering the sensor configuration and its sequence choice,
and we will characterize how the sensor affects and is affected by the cellular context. Second, to enable the
quantitative distinction of different trigger levels and the integration of multiple triggers, we will engineer
threshold-setting modifications and AND logic gates. Third, leveraging the unique post-transcriptional nature of
such sensors and gates, we will combine them with mRNA or an oncolytic RNA virus as delivery vectors, which
has traditionally been difficult to control. Last by not least, we will validate the performance and the therapeutic
potential of the sensors, gates, and the RNA vectors in cancer cell lines.
The future directions of the proposed project include continual optimization of the sensors, logic gates,
and vectors, testing them in more realistic cancer models including mouse models and patient-derived organoids,
and applying the tools to other fields.

Public health relevance
Relevance to Public Health This project aims to develop a tool that expresses specific proteins in cells in response to the presence of specific RNAs. A molecular tool like this will give us unprecedented specificity, if we want to specifically detect cancer cells and destroy them. The impact will be felt not only in cancer therapies but also other biomedical fields that require the observation/manipulation of specific cells.